Central Control and Neuroinflammatory Mechanisms of Locomotion in Older Adults with HIV

Mobility impairments including gait disorders and falls are debilitating and common, yet poorly understood in
older persons with HIV (OPWH). The fronto-striatal circuitry is critical for brain control of locomotion and has
been shown to be disrupted in HIV. Inflammation persists in HIV despite effective antiretroviral therapy and is a
key driver of cognitive impairment among persons with HIV (PWH); the frontal cortex, which supports motivation
and learning, is particularly vulnerable to the adverse effects of ongoing inflammation in the context of treated
HIV, placing OPWH at risk for resulting mobility disorders. The role of brain circuits and neuroinflammation in
gait and falls in OPWH has not been investigated to date, including whether walking performance under attention-
demanding conditions could be durably improved with training, and thus amenable to remediation. We propose
to use a validated dual-task walking paradigm (predictive of falls in older persons), a burst measurement (i.e.,
repeated trials) design, and functional-near-infrared spectroscopy (fNIRS) to determine the effect of HIV on brain
activation levels and trajectories of walking in 120 OPWH (age ³ 50ys) and 120 controls without HIV. We will
use multiple MRI methods to determine disruptions in the fronto-striatal circuitry and select markers of
neuroinflammation to identify mechanisms of brain control of walking and risk of falls in OPWH. Brain activation
patterns and learning trajectories of walking and improvements in their efficiency due to practice may be novel
biomarkers to identify OPWH at risk of developing mobility impairments and falls as they survive into older age.
Findings from this study will direct physical, cognitive, and pharmacological treatments to improve functional
brain control of walking, which in turn will lead to interventions to reduce fall risk in OPWH.

Public health relevance
Walking impairments and falls are debilitating and common but poorly understood in older persons with HIV (OPWH). This study will examine the effects of brain structure and function and inflammation on walking performance and risk of falling in 240 persons with and without HIV age 50 years and older. This interdisciplinary proposal is designed to improve our understanding of neural and inflammatory mechanisms underlying distinct negative effects of HIV on cognitive control and brain efficiency of locomotion in OPWH and has potential to improve early detection of and direct treatment for mobility impairments and falls in OPWH. the the